Biomedical-Behavioral Interface: Prevention and Developmental Sciences Training

This predoctoral training program focuses on interdisciplinary training of future behavioral scientists organized
around research concepts and methods at the interface of behavioral and biomedical domains. The program’s
cross-cutting theme emphasizes prevention, developmental, and translational sciences, and is grounded in
human and animal-model research. The predoctoral Behavioral-Biomedical Interface Program (BBIP) began in
the context of the NIGMS initiative “Interface of the Behavioral and Biomedical Sciences”. BBIP draws trainees
from three disciplinary units that are heavily involved in the behavioral sciences: Epidemiology, Exercise
Science, and Psychology. The behavioral and biomedical sciences faculty mentors and BBIP traines are
working on health-related research problems linked for example to obesity and physical activity in childhood
and adulthood, children’s behavioral and social-emotional health, cancer, stroke and brain injury, HIV,
substance abuse, cardiovascular health, and homelessness in chronically disabled populations. Providing the
cross-disciplinary training are faculty mentors, laboratory hosts, program leaders, and course instructors who
bring to bear a broad array of disciplines such as biological sciences, epidemiology and related public health
areas, exercise science, genetics, geriatrics, environmental health sciences, neuroscience, pharmacology,
physiology, prevention science, psychology, and quantitative methods/biostatistics. BBIP training during years
one and two includes: courses in neuroscience, genetics, endocrinology, and responsible conduct of research;
three laboratory rotations exposing trainees to a variety of research methods and perspectives; and a
behavioral-biomedical interface seminar. Training during years three thru five includes: seven BBIP sessions
per year on scientific, methodological, career and professional development, and scientific integrity topics;
colloquia by biomedical researchers; engagement and practices by faculty and students to foster a positive
multi-disciplinary climate; advanced quantitative/statistical skill development; and dissertation research
informed by behavioral-biomedical interface issues. This training program is designed to build capacity with
respect to behavioral scientists who are sufficiently exposed to the biomedical sciences to effectively contribute
on multi-disciplinary teams engaged in research aimed at understanding and preventing significant health
disorders and conditions, and promoting positive health outcomes.

Public health relevance
Project Narrative This institutional training grant supports the Behavioral-Biomedical Interface Program, which helps to prepare future behavioral scientists to be better equipped to address the complex challenges inherent in health research. Pre-doctoral trainees in public health and psychology disciplines acquire important foundations of biological and biomedical subject matter related to the brain, hormonal functioning, and genetics. This endeavor will contribute scientists to the workforce who are able to contribute significantly to multidisciplinary teams working to better understand and prevent health disorders and conditions of major societal import.